Western States Cancer Research NCORP

Project Summary
By serving as a dedicated NCORP, the Colorado Cancer Research Program (CCRP) seeks to advance cancer
research for patients, local communities, healthcare providers and hospitals in the Western mountain state
region. The goal is to provide and maintain access to NCI research and trials focused on cancer control (CC),
cancer prevention (CP), cancer disparities, cancer care delivery (CCDR), as well as provide access to NCTN
treatment and imaging trials. In the next funding cycle, CCRP has developed strategic partnerships with
regionally focused mid-sized Healthcare systems whose organizations have a common ethos of patient-
centered high value care and a shared commitment to implementing NCI trials in the community setting. The
consortium is diverse in its membership, not only from a regional perspective, but also in regards to the make-
up of its providers of healthcare services, ranging from Healthcare Systems, to Independent Hospitals, to
private practice physician offices. This diversity of recruitment sites will allow for broader participation in
NCORP projects, so as to achieve CCRP’s main goal of providing patients and communities within its
catchment area, the opportunity to participate in and potentially benefit from the innovative and scientifically
rigorous research projects of the NCI.

Public health relevance
Project Narrative The Colorado Cancer Research Program is a cancer clinical trial research organization who seeks to provide access to NCI sponsored clinical trials for our consortium members located in the mountain states of Colorado, Wyoming, Montana, Utah, Washington and Alaska. By partnering with Healthcare systems and community hospitals, we will provide access to innovative therapies and cancer related research projects for patients in their home communities, all the while, pursuing and supporting NCI strategic research priorities. We work with Healthcare systems, Hospitals, Providers and Patients to disseminate knowledge about clinical trial options, clinical trial participation, and clinical trial outcomes.